Circuitry-Guided Smoking Cessation in Schizophrenia

Project summary
While available tobacco smoking cessation aids, therapies, and public health efforts have reduced the overall
smoking rate, patients with schizophrenia spectrum disorders continue to have high rate of smoking. Recent
imaging research has identified key brain circuitries likely contributing to the high rate of smoking in these
patients, in an overlapping pathophysiological neural circuitry between schizophrenia and nicotine addiction.
Targeted correction of this overlapping circuitry may improve the patients' chances of success in quitting
smoking. The proposed study is to use a novel approach to design rTMS treatment that is based on a neural
circuitry mechanism on nicotine addiction in schizophrenia. The project will recruit patients with schizophrenia
spectrum disorders and randomize patients into active rTMS versus sham rTMS groups followed by fMRI
based target engagement outcome assessments. The proposal will use new stimulation site conceptualized to
be more closely linked to neural circuitry mechanisms of nicotine addiction in schizophrenia. The proposal will
include two phases as two separate projects. The first proposed project is a UG3 for two years. If the Go/Nogo
milestones are not met, the study will end. If all Go/Nogo milestones are met, it will proceed to a UH3 project
for another three years. The trial will test the proposed mechanism of action at brain circuitry level and
determine whether the new stimulation site will indeed significantly engage the proposed circuitry through
modulating its functional connectivity in the direction for helping patients to reduce and quit smoking.

Public health relevance
Project Narrative The project proposes to use transcranial magnetic stimulation to modulate the brain circuitry associated with nicotine addiction and schizophrenia, and to determine whether it would help patients to reduce and quit smoking.